Modified-release Hydrocortisone Therapy as a Treatment for CAH

This study has completed enrollment of all 16 participants. Pharmacokinetic data has been obtained on all patients. This clinical trial has ended and data analysis is underway. Chronocort is a modified release therapy that delivers hydrocortisone in a manner that mimics the bodys normal circadian rhythm (the bodys natural, 24-hour hormone cycle). This therapeutic approach has the potential to help patients suffering from diseases due to cortisol deficiency: congenital adrenal hyperplasia and adrenal insufficiency. Each of these diseases requires life-long treatment and this novel approach to drug delivery has the potential to significantly improve patients lives.